Therapeutic intervention to target human glaucoma pathogenesis

Project Abstract
Glaucoma is a silent, underdiagnosed, costly and debilitating disease. The prevalence of glaucoma is expected
to reach 80 million by 2020. Direct economic costs for the approximately 2 million US citizens with glaucoma
amount to $2.9 billion. The disease is complex and to date, treatment options for the disease only include
reducing elevated intraocular pressure (IOP). However, patients are sometimes resistant to conventional drug
therapies, and it is crucial to identify therapies and develop new treatments for glaucoma that can save retinal
ganglion cells (RGCs) from neurodegeneration. Our relevant proposed studies will provide a foundation for
developing a new glaucoma therapeutic that is a neurotrophic factor, human Neuritin 1 (hNRN1). The
utilization of hNRN1 is twofold; firstly, it enables the development of a soluble therapy that can promote
neuroregeneration of RGCs, and secondly, we can validate the neuroprotective effect in control and
glaucomatous RGCs under normal and elevated translaminar pressure conditions. These studies will
substantiate the therapeutic potential of this therapy for future patient-specific translational research. Further,
we will utilize our established novel ex vivo human perfusion model. This model allows for independent
regulation of both simulated IOP and intracranial pressure in human donor eyes, which can exploit the effects
of translaminar pressure on RGCs by mimicking the in vivo glaucomatous paradigm. The combined use of
stem cell technology, collagen constructs, and human donor eye perfusion model is an original approach to
study glaucoma. Our goal is to validate the therapeutic effects of neuritin1 in patient RGCs. Our central
hypothesis is that increased hNRN1 expression exerts a protective effect against human RGC
degeneration caused by glaucomatous NT deprivation and elevated translaminar pressure. To examine
this hypothesis, we propose the following specific aims:
AIM 1: Determine the neuro-regenerative role of human NRN1 in glaucomatous hiPSC-RGCs.
AIM 2: Determine the therapeutic role of hNRN1 to rescue degeneration of HTG RGCs from elevated IOP.
AIM 3: Assess the therapeutic potential of hNRN1 in preventing NTG RGC neurodegeneration.
Our powerful tools and valuable stem cell resources will have enormous potential for breakthrough discovery.
Utilizing hNRN1 as a therapeutic to overcome glaucomatous degeneration of RGCs will allow us to exploit the
most significant resources that can be translatable to clinical studies. It will offer a foundation for deciphering
survival and regeneration of RGCs due to glaucomatous neurodegeneration.

Public health relevance
Project Narrative Glaucoma is a disease identified by increased pressure within the eye and progressive death of neurons in the back of the eye that eventually leads to blindness. Current treatment options for disease only include reducing elevated pressure, but patients are sometimes resistant to established treatments. We will use human neurons and a regenerative therapy to rescue visual neurons from dying which will provide progress towards clinical trials in glaucoma patients with a focus on precision medicine.